Environmental Agents as Modulators of Disease Processes

Abstract of Parent Award
The overarching goals of the Rochester Environmental Health Sciences Center (EHSC) are to prevent disease and improve
health by advancing innovative and impactful translational environmental health research, engaging communities to address
environmental health issues, and enhancing career development of talented environmental health investigators. More
specifically, the goals of the Center are to: (1) enrich the ability to hypothesize and implement cutting-edge translational
environmental health research using modern approaches that also move knowledge into action; (2) advance science by
stimulating the prediction and prevention of detrimental exposures on health across the lifespan by developing and using
the best available tools and approaches, and integrating new information to understand cumulative risks; (3) promote career
development of the next generation of environmental health investigators in a diverse, inclusive, supportive, and
collaborative environment; (4) foster interactions of Center members and community partners to cultivate new ideas and
respond to issues of concern at the local, national, and international level; and (5) support existing and build new institutional
and inter-institutional partnerships. The Rochester EHSC achieves these goals by providing a framework that is anchored
in our overall mission to improve public health through the generation of fundamental knowledge and elaboration of
mechanisms by which chemical exposures, alone or through interaction with other modifying factors, contribute to
cumulative health risk across the life span. A key strength of the Center is that activities are not siloed within the study of a
specific organ system or a single disease. As such, the central theme that integrates EHSC research and community
engagement programs is the desire to understand how exposures and interactions of environmental factors affect health and
disease across the lifespan. This theme weaves together and synergizes Center member efforts, such that the totality of our
impact is greater than each part would achieve on its own. Further supporting the Center is a strong tradition of emphasizing
and integrating basic mechanistic research in model systems with clinical and epidemiological approaches, which catalyzes
multidirectional transformation of new information into actions. The Center also sustains strong community partnerships
that develop, advise, and also learn from new methods and engage diverse communities in our region and across the nation.
Unique and expanded strengths of our Center combined with emerging new areas underlie proposed Center activities,
programs, and use of resources, and provide the foundation for future success. Further supporting our success is the broad-
based scientific diversity of our faculty, which ideally positions us to apply integrative and innovative strategies to address
critical questions in environmental health sciences.

Public health relevance
Project Narrative of Parent Award The mission of the Rochester EHSC is to improve health through the creation of knowledge and discovery of mechanisms by which environmental exposures, singly and in combination, contribute to health risk across the life span, and translating findings into strategies to mitigate risks and improve human health. This mission is achieved by supporting scientific research and translating this research through community engagement and education. Thus, the EHSC provides the framework for the generation of novel research discoveries and their conversion into effective resources for scientists, public health officials, medical professionals, and communities.